Somatic Mosaicism across Human Tissues Program: Genome Characterization Centers (GCC SMaHT)

ABSTRACT:
As a supplement to our proposal, “Mosaicism in Human Tissues, from Telomere to Telomere,” we will help
establish a benchmarking approach using to a hypermutated cancer cell line (COLO829) and the paired
normal lymphoblastoid line (COLO829BL) derived from the same individual. Advantages of the COLO829
system as a somatic reference standard include a large (>20,000) number of defined somatic variants,
diversity of variant types (single nucleotide variants and structural variants), and, most importantly, the
presence of somatic variants in their native haplotype context. This last point is essential for validating the
ability of long-read sequencing to identify variants, particularly in the traditionally “unmappable” segments of
the genome that are precisely the areas likely to contain some of the highest rates of somatic mutation. Lastly,
the COLO829 system is already well-characterized and immediately available for purchase (ATCC) and does
not require any specialized methods for generating or maintaining cells. Specifically, we will create the
following three resources that will be useful for furthering the mission of the SMaHT network:
1. We will establish near telomere-to-telomere (T2T) genome assemblies of both the COLO829 and
COLO829BL cell lines, which will enable us to have a gold standard reference of true positive genetic
variants across the entire genome for subsequent mixing experiments.
2. We will apply our Genome Characterization Center’s (GCCs) sequencing approach to the COLO829
and COLO829BL cell lines, as well as in vitro and in silico mixtures of these cell lines, providing
datasets that can be used to validate computational approaches for identifying somatic variants at
variant allele frequencies ranging from 0.1% to 10%.
3. We will generate pre-mixed versions of the COLO829 and COLO829BL cell lines that can be provided
indefinitely as renewable “pseudomosaic” material for benchmarking the detection of low-level somatic
variants across all of the SMaHT network centers.

Public health relevance
NARRATIVE: The primary challenge of cataloging somatic variants is balancing the sensitivity of low-frequency variant detection with false discovery genome-wide, across multiple types of somatic variation. Determining the precision and recall of each GCC’s sequencing approach across a broad range of variant types, variant allele fractions (VAFs), and genomic loci is critical to the SMaHT consortium’s overarching goal: building a single, unified catalogue of somatic variation across 150 donors. As a supplement to our proposal, “Mosaicism in Human Tissues, from Telomere to Telomere,” we will help establish a benchmarking approach using to a hypermutated cancer cell line (COLO829) and the paired normal lymphoblastoid line (COLO829BL) derived from the same individual.